Asthma Clinical Core

The "Asthma Clinical Core B" will be a resource to provide well characterized subjects and specimens from cohorts of asthma and control subjects (bronchial brushings, BAL, endobronchial biopsy, sputum, blood, lung tissue) that will be used in each of the three projects comprising this AADCRC (Broide, Project 1;Croft, Project 2;Zuraw, Project 3). These specimens will allow investigators in the AADCRC to determine whether the inflammatory and remodeling pathways they are studying are differentially regulated in asthma compared to a control population. In addition to the cross sectional cohorts of asthma and control subjects. Core B will also provide specimens (sputum, blood, BAL, bronchial brushings, endobronchial biopsy) from well characterized asthmatic subjects obtained before and after allergen challenge, as well as before and after rhinoviral challenge. Overall, the provision of these specimens from asthma and control subjects will allow the individual projects to determine whether defined inflammatory and remodeling pathways are different in asthma compared to control subjects, as well as determine whether these inflammatory and remodeling pathways are regulated to be expressed by two common precipitants of asthma namely allergen and virus.

Public health relevance
Inhalation of airborne allergens such as cat and dust mite or respiratory viruses may result in damage and scarring of the bronchial tubes in susceptible asthmatics. This project will provide increased understanding of the cause of this scarring and suggest potential ways to identify asthmatics at risk for developing scarring of their lungs, or potential new treatments.